Computational Modelling of Perceptual Information Accumulation in Blind Individuals

Project summary
This project aims to investigate the process and mechanisms of echoacoustic information accumulation in blind
individuals by comparing their behavioral performance and brain activity with that of sighted controls, and a
consequent creation and training of a dynamic computational model. Echolocation, a skill that allows blind
individuals to navigate their environment using auditory cues, presents a unique opportunity to study
neuroplasticity and sensory substitution. The study will employ behavioral tasks and EEG recordings to
examine how auditory information is processed and accumulated in the brain, focusing on the temporal
dynamics and neural correlates of this ability.
Participants will be separated into two groups: a test group of blind individuals proﬁcient in echolocation
and a control group of sighted people naïve to echolocation skills. Behavioral tasks will involve locating and
identifying objects using auditory clicks in a controlled environment, while EEG will be used to record brain
activity during these tasks. The study will also incorporate computational modeling, including a dynamic
neural network to simulate the accumulation of sensory information over time. This model will be trained on
and validated against the collected data to understand how neural processes correspond to behavioral
performance.
The research will address key questions about how the brain adapts to the loss of vision by enhancing
other senses, speciﬁcally auditory processing. By comparing the performance and neural activity of blind and
sighted individuals in a dynamic system, the study aims to uncover diﬀerences in sensory processing
strategies and the underlying neural circuitry. The ﬁndings could have broad implications for the development
of training programs for echolocation and other sensory substitution techniques, as well as for our
understanding of neural plasticity in general.
The study is designed to minimize risks to participants, with appropriate protections in place for
recruitment, informed consent, and data conﬁdentiality. The expected outcomes include a detailed
characterization of the neural mechanisms of echolocation, insights into the temporal dynamics of
echoacoustic sensory processing, and a validated computational model that can predict neural responses based
on behavioral performance. This research has the potential to advance the ﬁeld of sensory neuroscience and
contribute to the development of assistive technologies for the blind community.

Public health relevance
Public health relevance By understanding how echoacoustic signals accumulate in the brain to drive decision-making, we could help improve existing strategies used in intervention and training programs, develop eﬀective sensory substitution techniques, and drive the creation of new assistive technologies. Our dynamic model of perceptual and sensory signal accumulation, made publicly available, will propel empirical research and make the ﬁeld more multidisciplinary and accessible to other research labs. All these factors could reduce the social and economic burdens associated with blindness, making this research highly relevant to public health goals.